The Health Consequences of Urban Scaling

PROJECT SUMMARY The COVID-19 pandemic has killed more than 100,000 people in the US, where very wide inequities in COVID- 19 outcomes have been reported for racial/ethnic minorities, including Hispanics. Hispanics suffer from specific social vulnerabilities that lead to increased risk of infection, and increased prevalence specific risk factors that lead to increased risk of severe illness. However, the number of confirmed cases in Hispanics may be severely underestimated due to differential coverage of testing by area and population group. Moreover, most preliminary measures of inequities in mortality have ignored the role of the different age structure of racial/ethnic groups. Creating consistent estimates of racial/ethnic inequities in COVID-19 outcomes is therefore key to exploring trends and predictors of these inequities, as a first step to improve the targeting of future interventions. Concurrently, several non-pharmaceutical interventions (NPI) have been deployed to control the pandemic, The capacity of racial/ethnic minorities to adhere to or benefit from (NPI) has been limited by several structural barriers, including deficient social safety nets, a lower possibility of teleworking and a higher likelihood of working in essential occupations. Overall, these structural constraints make isolation more challenging and increase the likelihood of exposure to infection even in areas with social distancing. Continued viral transmission in specific population subgroups makes the control of the pandemic more challenging for the entire population, and the emergence of future waves more likely. In summary, Hispanics are one of the racial/ethnic groups most impacted by the pandemic and, concurrently, one of the groups least able to benefit from NPI. For the current and future waves of the pandemic, it is imperative to reduce the risk of infection across the population to reduce community transmission; therefore. Therefore, understanding where and why health inequities are wider and whether NPI work across different groups is key to preventing future waves by reducing overall levels community transmission. We propose to systematically examine trends and predictors of heterogeneities of health inequities in COVID-19 outcomes between Hispanics and non-Hispanic whites (NHW), and between the neighborhoods where they predominantly live, across and within US cities, and the potential unequal effect of NPI in Hispanics vs NHW. We will leverage data on COVID-19 outcomes by race/ethnicity and neighborhood from the 30 largest cities of the US, corrected for imperfect testing quality and coverage; (2) social inequality measures; and (3) a diverse set of compilations of state-, county- and city-level policies. By using a heterogeneous sample of cities, we will uncover inequities and predictors of these inequities that will allow for more specific targeting of interventions that may prove key in continuing to control current waves of the pandemic and to prevent future waves. We will also demonstrate whether NPI may be less effective in Hispanics or predominantly Hispanic neighborhoods. Since NPI remain the most effective tool for epidemic control, their failure on specific population subgroups represents a hazard for the entire population. Drexel Internal Data

Public health relevance
PROJECT NARRATIVE Hispanics have been one of the racial/ethnic groups most impacted by the COVID-19 pandemic in the US and, concurrently, face some of the strongest structural barriers to benefit from non-pharmaceutical interventions. The proposed project proposes to uncover variability, trends, and predictors of inequities in COVID-19 among Hispanics, and to demonstrate whether these inequities grow with the implementation of interventions. Since NPI remain the most effective tool for epidemic control, their failure on specific population subgroups represents a hazard for the entire population. Drexel Internal Data